New Catalytic Stereoselective Strategies for Hydrocarbon Functionalization Via Ionic Intermediates

Project Summary
Chemical methodologies for the predictable transformation of hydrocarbons to functional synthetic intermediates
have revolutionized the preparation of small-molecule therapeutics. Nonetheless, the continued development of
new chemical tools that compliment current existing technologies and address gaps in synthetic strategy offer
the potential to further accelerate drug innovation and imaging techniques. The goal of this proposed research
program is to develop new areas of asymmetric catalysis by means of chiral ionic intermediates. More
specifically, the two research areas proposed here are centered on the study of catalysts that promote the
stereoselective trapping of cationic intermediates to address longstanding challenges in synthesis. The first
research area will focus on the development of novel strategies for catalytic enantioselective halogenation via
chiral Lewis base catalysis. This work draws upon our initial findings in this area regarding the Lewis base
activation of latent halide sources for the catalytic generation of chiral halogenating reagents. The second
research area details a conceptually novel approach for the generation of chiral molecules via hydride abstraction
processes. Specifically, we aim to exploit the reactivity and selectivity of superacid catalysts to enable the regio-
and stereoselective functionalization of saturated hydrocarbons. This strategy represents the starting point for a
broader research program aimed at developing a new mode of asymmetric Csp3–H functionalization. Taken
together, these research programs will expand the available chemical space and streamline chemical synthesis
for drug discovery and development.

Public health relevance
Project Narrative The efficient preparation of small molecule therapeutics is contingent upon the availability and diversity of chemical tools. Moreover, the synthesis of pharmaceutically relevant chiral molecules presents an even greater synthetic challenge if isomerically pure compound is necessary in order to minimize potential off-target biological effects. The goals of this proposal aim to develop new chemical tools for the highly selective upgrading of hydrocarbon feedstocks to value-added chemical building blocks, further abridging synthetic sequences and improving access to drug-like molecules.